Parent-to-parent peer navigation to improve respite access for children with medical complexity and their parent caregivers

PROJECT SUMMARY/ABSTRACT
The rapidly growing population of >1 million children with medical complexity (CMC) confers 40% of pediatric
healthcare costs, yet this calculation does not account for most of their intensive care. Parents and other family
caregivers provide 24/7 care with minimal assistance and no breaks. As medical innovation enables CMC to live
longer, parents’ constant work of care over decades jeopardizes their physical and mental health, their capacity
to safely care for their children, and thus, the parent workforce on which the U.S. healthcare system depends.
CMC parents report that respite – short-term direct care allowing caregivers a break – is critical to their well-
being and to sustaining caregiving over time. Despite this, most CMC parents lack access to respite. To date,
predictors and patterns of respite access nationally remain unknown, and there have been no rigorous
intervention studies targeting improved access.
Augmenting respite access for this stigmatized, understudied population is an urgent child health
research priority. In my two-center, qualitative study of CMC parent respite experiences, parents reported no
bandwidth to pursue respite care and trust only other parents to navigate resources. In response, I co-designed
the first parent-to-parent peer navigation intervention to improve respite access. RECHArge (Navigating
REspite REsources for parents of CHildren with medical complexity to improve Access) trains and employs CMC
parent navigators to empower and guide CMC parents in accessing respite services.
The proposed five-year research plan aligns with key NICHD research priorities to pursue three Specific
Aims: (1) co-design and iteratively refine the RECHArge navigator training curriculum and corresponding
intervention manual, (2) pilot test RECHArge to evaluate feasibility/acceptability and explore preliminary effects
on respite access and parent/family well-being at two Massachusetts-based sites, and (3) identify predictors and
patterns of respite access among CMC parents nationally with a focus on social determinants of health (SDOH).
As an M.D.-Ph.D. investigator with training in pediatric palliative care, complex care, and anthropology, I am
uniquely positioned to conduct the proposed study. Nonetheless, I need new skills for a career in intervention
science. My four Training Aims fill important gaps in my knowledge and experience to prepare me to
transition to career independence: (1) user-centered curriculum design, (2) RCT design and conduct, (3) social
determinants of health measurement and analysis, and (4) pediatric palliative care leadership.
I aspire to become an independent physician-investigator at the intersection of pediatric palliative care
and pediatric complex care. Successful completion of the proposed research and training aims will prepare
me to develop a multi-site, R01-funded efficacy trial. Accordingly, this project is the essential next step toward
my long-term career goal of building an independent research program to improve well-being and quality of
life for CMC parents and thus quality of care for the children to whom they dedicate their lives.

Public health relevance
To improve respite service access for parents of the >1 million children with medical complexity (CMC), I co-designed the novel, parent-to-parent peer navigation RECHArge intervention. I now need additional skills in user-centered curriculum design, RCT design and conduct, social determinants of health measurement and analysis, and leadership to support my 3 Specific Aims: (1) to develop and iteratively refine a training curriculum and corresponding intervention manual for RECHArge parent respite navigators, (2) to pilot test RECHArge in a two-site pilot RCT to evaluate feasibility and acceptability, and (3) to identify predictors and patterns of respite access among CMC parents nationally with attention to population health outcomes. Successful completion of proposed training and research aims will support development of a future R01-funded, multi-site efficacy trial of the RECHArge intervention and my transition to an independent career as a pediatric palliative care physician-investigator. SUMMARIZED DESCRIPTION OF CHANGES In response to reviewer feedback, the proposal has been modified in three ways: Specific Aim 3 is to conduct a secondary analysis of de-identified respite-related data from the Children and Youth with Special Health Care Needs Research Network national survey of parents of children with medical complexity (CMC) to identify predictors and patterns of respite access among CMC parents across the United States. The original proposal specified that these predictors and patterns would focus on social determinants of health so that the subsequent efficacy trial and intervention adaptation could be designed to serve populations with the greatest need. The PI has clarified that federal funds will not be used to engage in any activities that are not aligned with NIH/HHS priorities and goals. Accordingly, this secondary analysis will identify predictors and patterns of respite access among CMC parents nationally with equal emphasis on all population health variables that influence individual-level intervention efficacy and thus may contribute to respite access/in-access. In parallel to the change described above, the Training Aim 3 will be modified. It was initially written as developing expertise in measurement and analysis of social determinants of health (SDOH) in psychosocial research. Instead – and in response to the reviewers’ recommendation to build skills in quantitative analysis and seek more comprehensive training in biostatistics, the training aim will focus on development of skills in univariable and multivariable/multinomial analysis, use of classification trees or LASSO (Least Absolute Shrinkage and Selection Operator), and spatial analysis by geographical region. The National Institute of Minority Health and Health Disparities (NIMHD) Health Disparities Research Institute (HDRI) course will be replaced by the Harvard Catalyst Applied Biostatistics Certificate Course. The Community Partnerships Consultant will focus on improving the connection between community partners and the research team to ensure that all research activities align with the values and priorities of parent and community partners. She will not focus specifically on health equity; instead, she will aim to optimize processes of community-based participatory research.